HEAL - This service is for Micro Contract for DMPK Expert services for BPN, HEAL and Biologics. Incumbent is Devin Welty, PH.D.; POP: 07/01/2025 to 06/30/2026.

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.
Subject Matter Expert (SME) for Drug Metabolism Pharmacokinetics (DMPK) to support the Blueprint Neurotherapeutics Network for Small Molecule (BPN-Small Molecule) and NIH Blueprint Neurotherapeutics program (BPN)
The NIH Blueprint for Neuroscience Research, is a collaborative framework that includes the NIH Office of the Director and 12 NIH Institutes and Centers that support research on the nervous system, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and Contract Research Organization (CRO) support through Phase I clinical testing. Each project is directed by a Lead Development Team (LDT) composed of the Principal Investigator (PI), industry subject matter experts hired by NIH, and NIH staff. This team maps out a research strategy, including milestones, and oversees implementation by CROs. Bioactivity and efficacy studies are funded through an award to the PI; other research services can be provided without cost to the PI through NIH contracts.